Immunotherapy to deplete key Treg subsets in solid tumors

Abstract
Solid tumors such as non-small cell lung cancer and melanoma afflict more than 250,000 Americans per year.
While immunotherapies such as checkpoint inhibitors (CPIs) have improved cancer cure rates, they are only
effective in 20-40% of patients; hence there is a significant unmet need to improve solid tumor treatment
outcomes. Regulatory T (Treg) cells, classically defined as CD4+CD25+FoxP3+ T cells, are a key target for cancer
immunotherapies since they inhibit anti-tumor T effector responses, promote tumor progression, and correlate
with poor treatment outcomes. Reducing tumor-associated Tregs would enhance innate anti-tumor immune
responses and would also be likely to improve the activity of CPI immunotherapies. Indeed, a Treg-depleting
immunotherapy, Ontak® which targets the CD25 molecule (abundant on Tregs) was on the market from 1999-
2011, but critical drawbacks, including 25% rate of vascular leak syndrome (VLS) and significant manufacturing
inconsistencies, led to its removal from the market. A “cleaner” version of Ontak with additional purification steps,
Remitoro, was approved for human use in Japan in March 2021, but still shows high levels of VLS. The need for
safe, effective anti-cancer agents targeting Treg cells remains. To address this need and advance the field
of Treg-depleting immunotherapy, Sonoval is developing a second-generation version of Ontak, called
SON-211. By modifying a key VLS-inducing domain of Ontak, Sonoval has virtually eliminated VLS in SON-
211, while full its cytotoxic potency against Tregs is retained. Sonoval also holds IP on a novel production method
that solves prior manufacturing problems. In Phase I equivalent results, SON-211 demonstrated potent anti-tumor
efficacy as a monotherapy, and showed significant anti-tumor synergy when used together with a CPI in murine
models of solid tumors (melanoma, colon carcinoma, renal cell carcinoma). Recently, our team member, Dr.
Drew Pardoll, showed that the most highly immunosuppressive Treg subset in human tumors (OX40hi GITRhi)
strongly expresses CD25 (the direct target of SON-211 and Ontak), while another Tregs subset (Tbet IFNG) has
paradoxical antitumor effects and very weakly expresses CD25. These data suggest that SON-211—by
targeting CD25—may selectively eliminate the “bad” OX40hi GITRhi Treg subset and preserve the
beneficial Tbet IFNG Treg subset. Building from this strong and highly encouraging preliminary data, Sonoval
will leverage these key new findings to characterize the ability of SON-211 to selectively “re-balance” Treg
subsets in tumors towards a potent inflammatory anti-tumor population. Specific Aims of this Direct to Phase
II project are to: 1) Determine the effect of SON-211 monotherapy vs. no therapy on the balance of Treg subsets
in the TME; 2) Compare the effect of dual therapy with SON-211 plus an Anti-PD1 CPI on the Treg subsets; 3)
Optimize expression of SON-211 for production/purification.; 4) Demonstrate an ability to manufacture SON-211
at scale; and 5) Perform pre-IND, dose-finding and toxicology studies of SON-211 in Sprague Dawley rats.

Public health relevance
Narrative Solid tumors, including breast, lung, pancreatic, bladder, colon and ovarian cancers are a leading and rising cause of death worldwide. This project by the biotech company Sonoval will advance a novel anti-cancer agent that targets regulatory T cells (Tregs) for treatment of major solid tumors. By transiently and potently depleting CD25+ cells while being non-toxic to other cell types, Sonoval’s lead drug, SON-211, has the potential to address a critical need for effective new therapeutic options, and this study will characterize the drug’s action in tumors and initiate the pre-IND studies required for human studies.